MOPP VS RADIOTHERAPY FOR EARLY STAGE HODGKIN'S DISEASE

This study was designed to compare the response rates and toxicities of MOPP chemotherapy vs radiation in the management of previously untreated laparotomy-documented patients with early stage Hodgkin's disease. Of the 54 evaluable patients randomized to MOPP, 52 (96%) achieved a complete response; 7 relapsed. Forty-nine of fifty-one randomized radiation-treated patients (96%) achieved a complete response: 17 patients (35%) relapsed. Four MOPP-treated patients (7%) and ten (20%) radiation-treated patients have died.